Dissecting the Source and Mechanisms of IL-17-Mediated Modulation of Pancreatic Tumorigenesis

Abstract
The incidence of pancreatic adenocarcinoma (PDAC) is steadily increasing while most treatment modalities
remain ineffective. Therefore, it would not be a surprise to learn that PDAC is one of the top-4 causes of cancer-
related mortality. What is most striking about this malignancy is that even if detected at early stages, outcomes
remain poor. It is well known that pancreatic cancer is characterized by an immunosuppressive environment,
already found surrounding premalignant lesions or pancreatic intraepithelial neoplasia (PanIN), which has been
postulated as one of the main reasons for the lack of response to most therapies. However, the regulatory signals
that precede and support the development of this suppressive TME are not well characterized. The objective
of this grant extension is to characterize the gut cellular compartments and mechanisms implicated in the
intestinal IL-17 signaling dependent regulation of the gut microbiome and tumor growth and potential avenues
to reverse it through immune checkpoint blockade and microbial interventions. Our laboratory found that IL-
17-secreting immune cells play an important role in promoting pancreatic tumorigenesis in genetically
engineered mouse (GEMM) models of pancreatic cancer. Further, we revealed IL-17-IL-17RA signaling
specific to the gut epithelium plays a key role in modulating tumor growth through microbial regulation. We
now plan to characterize the cellular compartment within the intestinal epithelium responsible for modulating
IL-17/IL-17RA mechanisms. GEMM models with specific IL-17RA deletion in Intestinal Stem Cells and
Secretory Progenitor cells will be used to assess the cellular compartment regulating IL-17 effects (Aim 4).
Finally, we have recently found that mice with global elimination of B7H4 presented higher CD8+ T cells pancreatic
infiltration and, when using therapeutic antibodies blocking B7H4 in combination with aPD1 immunotherapy in PDAC
orthotopic models, a strong immune remodeling occurred. We now plan to definitively address the therapeutic
effect of B7H4 inhibition alone and in combination with immune checkpoint blockade in PDAC (Aim 5).
Achieving our goals will not only help us better understand immunological as well as microbial mechanisms
implicated in pancreatic tumorigenesis but will also result in practical novel interventions with either monoclonal
antibodies, narrow spectrum antibiotics or microbial transplants that would have a direct impact in preventing
and/or treating this deadly disease.

Public health relevance
PROJECT NARRATIVE One of the reasons that explains the high mortality of pancreatic cancer and the lack of responses to most therapies is the fact that the immune system is inactive around this tumor. In this grant extension we aim to characterize how specific gut cellular compartments modulate IL-17 signaling which ultimately affects pancreatic tumor growth, as well as potential avenues to reverse immunotherapy resistance in pancreatic cancer by targeting B7H4. We plan to study the mechanisms implicated in these events, which include IL-17 signaling in specific gut cellular compartments, its microbial modulation, and blockade of immune checkpoint molecules targeting IL-17 signaling to turn pancreatic cancer into a tumor sensitive to therapies.